The role of cytochrome bd in supporting flagellar motility in E. coli

PROJECT SUMMARY
This proposal will elucidate connections between bacterial aerobic respiration and flagellar motility in
uropathogenic Escherichia coli (UPEC), the primary cause of urinary tract infections. A major focus of our lab is
investigating the pathways that are essential for UPEC pathogenesis to aid in the development of new
therapeutic strategies. therapeutic strategies. Through our work, we have established that aerobic respiration is
crucial for UPEC's survival in the hypoxic environment of the bladder, with the quinol oxidase cytochrome bd
specifically required for colonization and proliferation inside bladder cells. Additionally, we observed that
cytochrome bd is essential for flagellar motility, a key fitness factor in UPEC. The requirement of cytochrome bd
for motility is surprising because UPEC encodes two other cytochrome oxidases that are functionally redundant.
Therefore, this proposal aims to elucidate the mechanism of how cytochrome bd supports flagellar rotation in
UPEC. My preliminary data suggests that cytochrome bd is required to support overall respiratory flux as mutants
lacking cytochrome bd have impaired proton flux across the membrane. Additionally, a prevailing unknown in the
field is whether enzymes are localized near the flagella to direcUy power flagellar rotation possibly through
interacting with the stator proteins MoWMotB. I hypothesize that cytochrome bd sustains flagellar motility
either through support of overall respiratory flux or physical interaction with the flagellar motor. This
hypothesis will be tested in two specific aims: Aim 1 will determine how loss of cytochrome bd affects respiratory
efficiency and Aim 2 will address the spatiotemporal relationship between cytochrome bd and the flagella. This
study will be the first to define a role for cytochrome bd in flagellar motility and address a critical gap in knowledge
of how flagellar rotation is energized. Given that cytochrome bd plays an essential role in infection, this
information will be vital in the development of novel antimicrobials.

Public health relevance
PROJECT NARRATIVE Uropathogenic Escherichia coli (UPEC), the pathogen responsible for >75% of urinary tract infections worldwide, requires the quinol oxidase cytochrome bd for virulence and flagellar motility. Flagellar rotation in bacteria is driven by the proton potential generated in the membrane by the electron transport chain (ETC), however the exact mechanism by which the proton flux is supplied to the flagellar motor remains undefined. This proposal will identify the novel mechanism through which cytochrome bd, a member of the UPEC ETC powers flagellar motility.